Same-sex marriage and health insurance coverage decisions by employers

PROJECT SUMMARY
We provide new evidence on the effects of legal access to same-sex marriage on
employer decisions about health insurance benefits for same-sex domestic partners of
employees. No prior work has used high quality employer surveys such as those we propose
to use here: the Medical Expenditure Panel Survey – Insurance Component has asked over
40,000 public and private employers about same-sex domestic partner health benefits since
2013. Together with restricted access to geolocation of the employer, we will examine how the
rollout of legal access to same-sex marriage affected decisions about these benefits, and we
will examine whether employer characteristics such as firm size or industry are systematically
related to the effects of legal same-sex marriage on these employer decisions.

Public health relevance
PUBLIC HEALTH RELEVANCE Rates of health insurance coverage and access to care are lower for sexual minorities than for heterosexuals in the United States, and the historically unequal treatment of same-sex partners with respect to health insurance has commonly been pointed to as one possible reason for these insurance disparities. We will provide the first direct evidence on how advances in legal access to same-sex marriage were related to employer decisions about offering health insurance benefits to same-sex partners of employees (as well as to unmarried different-sex partners of employees). More broadly, our results will be relevant for understanding how general changes in LGBTQ rights are related to employer health insurance decisions relevant for sexual minority populations.